Molecular Epidemiology and Surveillance Optimization of Clostridioides difficile in Asymptomatic Patients

Project Summary Clostridioides difficile (CD) is a ubiquitous, spore-former and the most prevalent healthcare-
associated infection. While infections are often triggered by antibiotics, particularly in immunocompromised
individuals, we know little about the factors and risks for triggering symptomatic CD infection (CDI).
The overarching objective of Dr. Cersosimo’s research is to understand the dynamics of CDI in at-risk
patient populations and optimize testing strategies for toxin C. difficile carriage to enable surveillance in broad
clinical settings. The proposed research uses advanced genomic-epidemiologic analyses to enhance our
understanding of CDI epidemiology in at-risk inpatients, identifies associations among C. difficile genomic and
antibiotic resistance profiles, and optimizes current hospital CD surveillance programs for deployment to a
diverse range of healthcare institutions. Aim 1 applies molecular epidemiologic strategies to identify patient and
strain-specific risks for the development of CDI. Subaim 1a defines the dynamics of infection risk in oncology
and ICU wards with genomic-epidemiologic analyses of CD in patients and using patient co-variate data obtained
from the electronic health record. Subaim 1b defines genomic and phenotypic drivers of strain antibiotic
resistance and their contribution to asymptomatic carriage and progression to CDI in inpatient oncology wards
versus other ICU settings. Aim 2 optimizes tools for CD surveillance through the a) development of a more rapid
and accessible clinical diagnostics assay for the identification of toxin positive CD and b) generation of
informative data that demonstrates antibiotic triggers of CD carriage to inform population-based CDI preventative
strategies in collaborations with clinical infection control and infectious disease pharmacy teams.
Dr. Cersosimo brings a One Health background per her previous training in animal gut health, clinical
diagnostics, and food science. Her prior experiences and training goals will: 1) optimize bioinformatic and
statistical approaches in the analysis of C. difficile genomic data, 2) advance her understanding of microbiology,
infectious diseases, epidemiology through hands-on learning in the healthcare setting, 3) develop strategies to
generate, analyze, and interpret high-dimensional genomic and phenotypic antibiotic resistance data to inform
strain genomic landscapes and associated hospital-focused antibiograms for C. difficile, and 4) improve her
professional and leadership skills to progress as an independent investigator studying questions in infectious
disease genomics and epidemiology from a One Health perspective. Her appointments at Brigham and Women’s
Hospital and Harvard Medical School provide access to state-of-the-art clinical, laboratory, and computational
resources and an internationally renowned mentoring committee with expertise in C. difficile epidemiology,
antibiotic stewardship, genomics, and hospital infection surveillance. Educational resources in infectious disease
epidemiology, advanced biostatistics, and clinical microbiology will further enable her training goals and career
progression to independence.

Public health relevance
Project Narrative Clostridioides difficile is the most common healthcare-associated infection, characterized by severe diarrhea and inflammation of the colon, with an estimated 500,000 cases per year in the U.S. and an annual economic burden of >$5 billion. We have an incomplete understanding of how antibiotic usage, forms of innate and acquired antimicrobial resistance among C. difficile strains, and patient co-variates, including immune status and other co-morbid conditions impact risks for disease development. My proposed research objectives will 1) support genomic-epidemiologic analyses of high-dimensional datasets with patient and epidemiologic data to improve our understanding of pathogen and patient factors that promote C. difficile colonization and infection and 2) optimize an active C. difficile hospital surveillance program through the development of more accessible clinical detection assays and functional antibiograms to better detect CD carriage as well as identify factors that may increase patient risks for carriage.